ADMIN CORE

Administrative Core Project Summary
Arizona patient safety net systems are traditionally siloed from one another with limited cross-organization
collaboration on shared interests and limited capacity for research engagement. The Southwest Safety Net
Embedded Scientist Training and Research Center (SSNE-STaR) will directly address this inherent
fragmentation with an engaging scholar training program and integrated learning collaborative, with the primary
focus of patient safety net healthcare systems. The Administrative Core (AC) will provide leadership for the
Center, coordinate proposed activities, maintain internal information flow across all Cores and Partner
Institutions, and liaise with AHRQ/PCORI agency staff. The AC has designed a program for effective Scholar
recruitment and retention, as well as Scholar project review and selection as guided by Core Leaders and
Mentors. AC will further identify and engage other stakeholders (healthcare systems, payers) who can
participate in our Rapid Implementation program as part of a broader integrated learning system across
multiple organizations. AC goals include: (1) coordinate and support all proposed activities; (2) maintain and
enhance internal and external information flow; (3) facilitate regular and meaningful engagement between all
stakeholders; and (4) evaluate all program activities and outcomes. These goals align with the mission of the
(SSNE-STaR) to build partnerships between health systems, academic health centers, community partners,
and other stakeholders. AC will demonstrate the value of LHS embedded training and research through
program evaluation activities and liaison with AHRQ/PCORI agency staff, ensuring that program objectives and
priorities, performance, challenges, and related information is communicated. AC Specific Aims include: (1)
develop effective approaches for the recruitment and retention of LHS Scholars and facilitate mentoring and
training relationships among Partner Institutions, and coordinate and support Scholar and Mentor activities, (2)
provide management and facilitation support to the LHS and all cores, and (3) facilitate evaluation activities.